Interaction of Mycobacterium tuberculosis with upper airway mucosal cells

Project Summary
The nasopharyngeal and respiratory mucosa represents a primary barrier to infection by inhaled organisms.
Indeed, the earliest contact point between the airway pathogen Mycobacterium tuberculosis and the human
body is the airway mucosa. As a result, M. tuberculosis has evolved to disseminate beyond the oral and
respiratory mucosa to cause systemic disease, thus accounting for its global impact on human morbidity and
mortality. Lining the airway mucosa are specialized epithelial cells that function to transcytose mucosal
antigens from the mucosal surface to the basolateral space. These cells, known as microfold or M cells, overlie
mucosal associated lymphatic tissue where macrophages and dendritic cells await to ingest and present
antigens to B-cells and T-cells. We previously demonstrated that M. tuberculosis penetrates the mucosa via M
cells by using a virulence factor called EsxA and a host receptor, scavenger receptor B1 (SR-B1). However, a
major gap in our understanding of the impact of this very early event on the interaction of M. tuberculosis with
the airway is that we do not fully understand M cell biology. Here, we will apply genetic, biochemical,
immunologic, transcriptomic and animal approaches to determine the functional role of M-cells in mucosal and
systemic immunity against M. tuberculosis. Thus, in the proposed research we will: (1) Determine the
transcriptional profiles and functions of novel genes of primary human and mouse airway M cells at a single
cell level under both homeostatic conditions and after experimental M. tuberculosis infection, (2) Identify and
study unique cell-cell interactions of M cells with their adjacent epithelial and immune cells, (3) Characterize
the mechanisms of binding and transcytosis of M. tuberculosis by airway M cells, (4) Determine the
immunologic impact of M. tuberculosis transcytosis across airway M cells. The proposed work is expected to
identify how M cells bind and transcytose M. tuberculosis and how this very early event in the life cycle of M.
tuberculosis dictates the immunologic outcome of infection.

Public health relevance
Project Narrative The airway mucosa is the initial site of interaction with Mycobacterium tuberculosis. While the mucosa itself forms a critical barrier to infection, it is also the anatomic location where cells of the mucosal, innate and adaptive immune systems converge to orchestrate protective immediate and long-term responses. We have demonstrated that M. tuberculosis can migrate and enter the mucosa associated lymphoid tissue via a rare, specialized cell type called a microfold cell. Here we propose to better characterize features of the airway M cell, establish how it communicates with other epithelial and immune cells, determine the mechanism by which the bacteria traverse the cell and the immunologic consequences of early microfold cell contact with M. tuberculosis. This approach is novel because it represents the first broad characterization of the role of airway microfold cells to host defense against M. tuberculosis.